Protein glycosylation and trafficking in Plasmodium falciparum

Project Summary
In all domains of life proteins are modified via glycosylation. This addition of sugar molecules to proteins
is critical for their folding, function, and recognition by their partners. Rigorous studies have shown that in
well-studied eukaryotic organisms, proteins synthesized in the endoplasmic reticulum (ER) are
glycosylated on asparagine residues as well as on serine or threonine residues. These modifications are
critical for the trafficking of proteins in the secretory pathway. Protein glycosylation acts as a marker for
protein folding to ensure only folded and functional proteins are sent from the ER. Once outside the ER,
glycans on proteins also act as critical recognition motifs to route proteins accurately to their correct
subcellular location. These glycan-centric mechanisms are found in almost all well studied eukaryotes.
Surprisingly, the intracellular eukaryotic parasite, Plasmodium falciparum, does not appear to utilize any
of these canonical protein glycosylation-based mechanisms to traffic proteins in its secretory pathway.
This parasite causes malaria, and the clinical symptoms of malaria are a direct result of its growth and
expansion with human red blood cells (RBC). The parasite depends upon protein secretion to ensure its
survival within the RBC. Even though glycan modifications on proteins are a major driver of immune
responses, we do not know if and how P. falciparum glycosylates proteins in its secretory pathway during
the clinically relevant asexual blood stages. In fact, the P. falciparum genome lacks several genes in this
pathway that are well conserved in other eukaryotic organisms, including other closely related parasites.
To fill this major gap in our knowledge, we will combine genetic and cellular assays to study if conditional
knockdown of the targeted glycosyltransferases inhibits protein trafficking within the highly branched and
unconventional secretory pathway of P. falciparum. Our preliminary data show that the parasite protein
glycosylation pathway genes are essential for parasite growth within the RBC. The experimental approach
will test if protein glycosylation also functions in an unconventional protein quality control pathway in the
parasite ER. We will utilize glycoproteomic approaches to determine the landscape of protein glycosylation
during the intraerythrocytic growth of P. falciparum. The collaborative research team will combine these
proteomic approaches with genetic tools to determine which glycosyltransferases are responsible for
which the glycan modifications. The specific glycosyltransferase activities will be validated using
complementation assays as well as in vitro assays using recombinantly expressed glycosyltransferase.
The tools and reagents developed for this project may find wider applicability in glycobiology and
parasitology. Given the importance of glycans in driving the host immune system, the proposed studies
may have important implications for our understanding of the antimalarial immune response.

Public health relevance
Project Narrative The obligate intracellular parasites from the genus Plasmodium grow within human red blood cells, causing a lethal disease called malaria. The proposed research aims to understand the parasite-specific glycosylation pathways required for transporting proteins to specific sub-cellular locations within the infected red blood cell. The proposed study will help us identify targets for novel targets for antimalarial therapies, which are sorely needed because Plasmodium has developed resistance to all currently available antimalarial drugs.